PROTROPIN ADMINISTERED DAILY AND TIW TO PATIENTS WITH GROWTH HORMONE DEFICIENCY

This study seeks to determine if daily administration of Protropin may result in more rapid growth than thrice weekly administration in children with growth hormone deficiency. ("D" protocol)